Neural Mechanisms of Cognitive Meta-Flexibility

Project Summary/Abstract
Adaptive behavior requires the ability to keep a current task set in mind and shield it from distraction (cognitive
stability), as well as to update task sets in response to changing requirements (cognitive flexibility). Cognitive
stability and flexibility are complementary but opponent processing modes, as greater stability comes at the cost of
lower flexibility, and vice versa. Importantly, neither a stable nor a flexible mental state is inherently beneficial;
rather, it is the adaptation of one’s flexibility level to varying environmental demands – or meta-flexibility - that
produces optimal cognition. Accordingly, adopting a contextually optimal set point in the stability/flexibility trade-off is considered a challenging (and poorly understood) “cognitive control dilemma”, and this ability is severely
impaired in many psychiatric disorders. Therefore, understanding the neural mechanisms that mediate meta-flexibility is of great significance to both basic and clinical brain science. However, whereas individual differences
and externally (e.g., drug-) induced changes in flexibility set points have been studied with some success, it is not
presently known how the brain produces strategic meta-flexibility, i.e., learning to adapt one’s flexibility level to
changing contexts. While a budding behavioral literature shows that people strategically adapt their readiness to
switch tasks in line with changes in contextual switch-likelihood, no study to date has examined the neural
mechanisms underlying these dynamic, learned changes in cognitive flexibility. Therefore, the overall goal of this
proposal is to foster a new understanding of strategic meta-flexibility. We triangulate this goal via 3 strategic aims:
in aim 1 we delineate the neural loci and mechanisms of meta-flexibility by combining proactive (Study 1) and
reactive (Study 2) cognitive flexibility learning protocols with functional magnetic resonance imaging (fMRI) and a
suite of cutting-edge analysis approaches, including brain state “pinging” and representational similarity (RSA),
multivoxel pattern (MVPA), and dynamic functional connectivity (dFC) analyses. In aim 2, we then move on to
determine the learning processes that guide the above mechanisms of strategic shifts in switch-readiness. Here, we
use model-based fMRI, multivariate measures of neural memory reinstatement, and fMRI-guided model-based
transcranial magnetic stimulation (TMS) to test how both “incremental” reinforcement learning (RL) (Studies 3 and
4) and episodic reinstatement (Study 5) may contribute to guiding strategic meta-flexibility. Having established the
basic brain mechanisms of strategic meta-flexibility, in aim 3 we then examine its potential clinical significance as
a transdiagnostic cognitive endophenotype, by leveraging large-scale online data collection to relate individual
differences in strategic meta-flexibility to variance in clinically relevant self-report measures (Study 6). We thus
lay the foundation for a potential computational psychiatry of cognitive meta-flexibility. In sum, this proposal is the
first systematic research program into neurocognitive mechanisms of strategic meta-flexibility, the ability to adapt
switch-readiness to suit changing contexts. This innovative project will significantly enhance our understanding of
how task-switching is regulated, and help identify potential failure modes of meta-flexibility in health and disease.

Public health relevance
Project Narrative In daily life, we sometimes need to have a strong and stable focus on a single task at hand, at the expense of engaging with alternative activities, while at other times we need to be more flexible, switching frequently between different tasks, at the expense of doing any one of them with the utmost focus. Being able to strategically shift between different brain states (ranging from highly stable to highly flexible) so as to best suit the current environmental demands is a crucial but poorly understood cognitive ability called “strategic meta-flexibility”, which appears to be greatly impaired in many psychiatric disorders. Therefore, the present research program uses non-invasive measurement and manipulation of brain activity in order to carefully characterize the neural mechanisms that allow healthy humans to strategically adapt their cognitive flexibility to changing contexts, so that we can ultimately better understand - and treat - deficits in cognitive meta-flexibility in clinical patient populations.